Barriers to Effective HIV Care for Injection Drug Users After Release from Prison

DESCRIPTION (provided by applicant): Candidate: My career goal is to improve the health of people living with HIV through interdisciplinary research aimed at reducing barriers to optimal HIV care for traditionally underserved patient groups. My short term goal is to establish myself as an independent investigator as a tenure-track junior faculty member at the University of Wisconsin-Madison, and to develop an innovative research program in collaboration with state and federal prison systems. Research Project: My proposed research uses an innovative, mixed-methods approach to comprehensively evaluate barriers to accessing continuous HIV care for people who become incarcerated. I propose three distinct aims which will address this question using different types and sources of data, in order to identify which factors causing suboptimal care are the most important and potentially amenable to intervention. Aim 1 will utilize longitudinal data from the AIDS Linked to the Intravenous Experience (ALIVE) study to examine individual and neighborhood-level factors associated with poor linkage to care following incarceration. Aim 2 will be an expanded analysis of HIV care outcomes that incorporates retrospectively-collected medical records data from correctional facilities for ALIVE participants who were incarcerated between 1998 and 2011. Aim 3 will confirm and inform the findings of quantitative phase of the study through semi-structured interviews with patients while they are receiving HIV care in prison, and follow-up interviews within several months after release to the community. Career Development Plan: My proposed training and mentoring activities will center around (1) attaining expertise in analysis of complex longitudinal data; (2) developing competence using qualitative research methods; (3) building partnerships with correctional agencies for HIV research; and (4) deeper understanding of ethical issues surrounding research in correctional settings. My applied research will be closely coordinated with my training activities, and will build toward an application for an R01-funded project in the fourth year of this award. Research Environment: I will be well-supported within the Department of Medicine at UW-Madison. In addition, I will benefit from the excellent research infrastructure of the ALIVE study at Johns Hopkins (Aims 1 & 2), and a large, NIDA-funded study of Seek, Test, and Treat Strategies for HIV in the WI Department of Corrections (Aim 3). PUBLIC HEALTH RELEVANCE: People in prison in the U.S. have a higher prevalence of HIV than the general population and may also be more likely to engage in behaviors that place others at risk for HIV when released back to the community. Developing strategies to ensure that incarcerated people continue to receive effective antiretroviral treatment after release may reduce the transmission of HIV in communities and decrease long-term complications of HIV infection.

Public health relevance
People in prison in the U.S. have a higher prevalence of HIV than the general population and may also be more likely to engage in behaviors that place others at risk for HIV when released back to the community. Developing strategies to ensure that incarcerated people continue to receive effective antiretroviral treatment after release may reduce the transmission of HIV in communities and decrease long-term complications of HIV infection.